Administrative Service

The administrative core manages the overall organization of the project, and is responsible for project progress and budgetary reporting to NIH through annual progress reports and other mechanisms. The purposes of the administrative core are to coordinate the efforts of the individual groups, fostering communication and cooperation, and to ensure equitable access of each project to the shared resources provided by the virology core. To this end, the administrative core organizes monthly meetings of the project team where scientific progress is reported and other business discussed. This core also maintains an electronic bulletin board for the groups, which facilitates and enhances communication among project participants. Papers submitted for publication by project leaders are also distributed among the members of the project on a regular basis through the administrative core, providing a mechanism for team input. This core also organizes the annual review of the overall project by the advisory committees.

Public health relevance
The administrative core organizes a research project involving multidisciplinary team of investigators to address fundamental questions in 'novel immune mechanisms against herpes viruses. The knowledge gained by these research projects is relevant to the prevention and control of human herpesviruses.